LYMphatics in Pathology and Health (LYMPH)

Although various research institutions and clinics in the United States successfully train graduate students in
cardiovascular biology, specific training in lymphatic biology is lacking. Lymph transport is critically involved in
body fluid regulation, macromolecular homeostasis, lipid absorption, inflammation, and immune function.
Lymphatic dysfunction is central to a number of pathologies, including primary/secondary lymphedema that
affect millions of people worldwide. A dysfunctional lymphatic system also compromises the immune response,
further exacerbating a number of inflammation-related diseases. Despite these known impacts, until recently
the scientific and medical fields have not sufficiently recognized the importance of the lymphatic system. NIH
has in recent years implemented several funding opportunities that specifically target lymphatic research. This
effort has stimulated the growth of lymphatic biology research over the last decade. However, one of the
important issues is the paucity of scientific investigators trained in lymphatic biology research. While this
number has grown somewhat over the years, it is still an important limiting factor in the growth of
understanding of the lymphatic system. Thus, this application addresses the need to create interdisciplinary
programs to train new scientific investigators in the field of lymphatic biology. The proposed LYMphatics in
Pathology and Health (LYMPH) Training Program will directly address this need. Indeed, the Division of
Lymphatic Biology group at Texas A&M University has been doing so for the last decade, but the additional
resources provided by this T32 award would greatly accelerate that process. This application requests support
for 2 predoctoral trainees per year and for two consecutive years. Experienced investigators at Texas A&M
University in the principles of lymphatic biology will offer predoctoral students strong, research-oriented training
focusing on the principles of scientific methods and techniques, translational approaches, scientific
responsibility and networking, scientific presentation and writing skills, as well as management and leadership
training at Texas A&M University. This will produce well-versed, broadly trained, independent scientists to work
in the field of lymphatic biology. A total of 23 faculty mentors are currently participating in this integrative
LYMPH Training Program and the mentors’ research expertise extends across a variety of research areas,
from genomics to molecular, cellular, imaging, developmental, immunological, and physiological phenotypes
related to lymph transport and lymph flow mechanisms. Successful accomplishment of these goals will result in
a new cadre of competent young scientists in the lymphatic biology area, who can successfully develop novel
approaches in lymphatic research to aid in further understanding of the pathogenesis of lymphatic related
diseases and to provide novel targets to improve lymphatic function, thus reducing disease in patients
worldwide.

Public health relevance
Although various research institutions and clinics in the United States successfully train graduate students in cardiovascular biology, specific training in lymphatic biology is lacking. Developing the next generation of scientists is vital for the successful pursuit of treatments for lymphedema and other lymphatic dysfunction associated diseases, cardiovascular, kidney, metabolic, cancer, and brain diseases. The LYMPH Training Program at Texas A&M University will help accomplish this goal.